CyTOF XT with Hyperion XTi platform

PROJECT SUMMARY
A group of eleven NIH-funded investigators requests funding for the purchase of a Standard Biotools CyTOF
XT mass cytometer with the Hyperion XTi imaging platform, for installation in the Cytometry and Cell Sorting
Core at Baylor College of Medicine. A primary application of the instrument will be the analysis of both cell
suspensions and tissue sections from human subjects and from rodent models of human diseases. The
investigators participating in this application are in two different institutions within the Texas Medical Center and
do research in the fields of immunology, cancerology, cardiovascular disease and neuroscience, and are at
various stages of their careers in academia. In addition to greatly advancing the individual research programs of
the users, the instrument will be available to all investigators at institutes within the Texas Medical Center and in
the greater Houston area, fostering collaborative research and providing an important regional resource.

Public health relevance
PROJECT NARRATIVE The installation of a CyTOF XT with a Hyperion XTi Imaging System BioSorter in the Cytometry and Cell Sorting Core at Baylor College of Medicine will enhance the capabilities, quality, and throughput of research projects of multiple investigators at Baylor College of Medicine and in surrounding institutes. These investigators focus on immunology, cancerology, cardiovascular disease and neuroscience.